Decoding and Rewiring Enzymatic Redox Signal Transduction Pathways

PROJECT SUMMARY
Cells have evolved intricate enzymatic machineries that help them exist and survive redox stresses in their
microenvironment. Enzymatic redox sense, signal, and response mechanisms are critical for a diverse set of
physiological processes in all forms of life ranging from bacteria and plants to humans. Unlike other cellular
signaling processes, redox signaling involves highly reactive reagents such as nitric oxide (NO), carbon
monoxide (CO), and reactive oxygen species that raise concerns regarding the potential of these reagents for
participation in other non-specific reactions. Yet, such side reactions are uncommon under physiological
conditions suggesting high specificity and selectivity of enzymatic redox signal transduction pathways. In turn,
we ask the following two pertinent questions: a) What makes redox signaling pathways so specific? and b) Can
we rationally and systematically rewire redox signal transduction pathways to re-instate/disrupt cellular redox
balance? These questions have been largely overlooked from the chemical biology and bioinorganic chemistry
perspective, despite the fact that redox imbalances are responsible for a variety of diseases ranging from
neurological disorders to cancer. Our lab focuses on these paradigm shifting questions and the long-term goal
of our research program is to develop molecular strategies that rewire sensing/signaling mechanisms of
biological redox reagents involved in human health and disease. In this proposal, we focus on DosS-DosR
enzymatic signaling pathway in mycobacteria that senses NO/CO in its microenvironment and signals cellular
transition into a non-replicating, dormant state. The DosS-DosR system has three components – a heme iron
sensing domain that binds to NO/CO, a zinc-dependent signaling kinase domain that communicates the binding
event and a response domain that binds to DNA and turns on dormancy. Using our combined expertise in
metalloprotein structure-function, protein engineering, enzymology and spectroscopy, we will devise mutagenic,
metal-substitution and peptidomimetic-based approaches to rewire DosS-DosR sense, signal and response
domains. Proof-of-concept studies conducted in our laboratory have demonstrated successful rewiring of DosS-
DosR redox sensing function via structure-guided rational protein design. Future work will unravel the molecular
mechanisms of redox rewiring and its implications on cellular physiology and phenotypic responses. Our findings,
will not only provide a fundamental understanding of cellular redox sense/signal/response mechanisms, but also
inform future methodologies for treatment and prevention of redox-related diseases.
Health Relevance: Maintenance of a normal intracellular redox status is crucial for regulating physiological
responses. Any imbalance in this status results in a variety of acute and chronic degenerative diseases such as
cancer, cardiovascular and neurological disorders. Our research program aims to design molecular approaches
that rewires the ability of cells to sense and signal redox changes in their environment. These approaches could
be applied to re-instate cellular redox homeostasis in diseased states.

Public health relevance
PROJECT NARRATIVE Similar to electrical circuits, cells possess enzymatic circuits that sense, signal and respond to the presence of redox-active stimuli in their microenvironment. We will design molecular strategies to rewire enzymatic redox circuitry that will enable cells to overcome excess or deficiency of critical redox reagents. These strategies will inform future methodologies for prevention and treatment of several redox-related diseases including cancer, cardiovascular and neurological disorders.